Research Studies Core

ABSTRACT: Research Studies Core
The National Dementia Workforce Study (NDWS) will be launched by a national team of experts in clinical care
of persons living with dementia, survey research, and health workforce research. The goal of the NDWS data
infrastructure is to allow researchers and policymakers to ask and answer scientific questions to help build the
workforce of clinicians and other professional care providers required by the growing population of persons
living with dementia in the U.S. The Research Studies Core will solicit research proposals to jump-start the
community of NDWS data-users to use the new NDWS data infrastructure to both answer important scientific
questions and build the community of workforce researchers. The aims of this core will be to: 1) Solicit, review,
and fund external research studies that will generate new insights into the professional dementia workforce; 2)
Use stakeholder input to develop themes for the research award calls and provide input to funded awardees;
and 3) Provide mentorship and support to facilitate successful completion of project milestones and increase
the likelihood of R01 funding.